Dzip1 and Mitral Valve Prolapse

Project Summary
Mitral valve prolapse (MVP) affects a significant portion of the population (1 in 40 individuals), yet its
potential severity has been underestimated. Recent findings indicate that a substantial number of MVP
patients develop left ventricular (LV) fibrosis, a serious complication. However, current surgical
guidelines often delay intervention until patients exhibit symptoms of LV dysfunction, leading to poorer
outcomes and increased mortality rates. Our research has unveiled MVP as a condition that impacts
both the heart valve and the ventricle, highlighting the need for routine monitoring of LV function and
consideration of cardioverter defibrillator implantation in MVP patients. This project aims to delve
deeper into the mechanisms underlying MVP-related fibrosis. By investigating how MVP induces
regionalized fibrosis, particularly in areas where tension forces are heightened, we aim to uncover the
role of increased tension as a driver of LV fibrosis in MVP. This multidimensional approach will provide
insights at the molecular, cellular, and tissue levels, contributing to a better understanding of MVP
pathology.

Public health relevance
PROJECT NARRATIVE Mitral valve prolapse (MVP) affects approximately 2.5% of the population, yet its underlying causes remain unclear. Research into the genetic and developmental aspects of heart valve formation may elucidate the reasons behind MVP and its associated cardiac complications, such as heart failure and arrhythmias. Unraveling these mechanisms holds the potential for improved prevention and treatment strategies for MVP and related heart conditions.